Chronic Pancreatitis Clinical Research Consortium (CPCRC) Data Coordinating Center (CPCRC-DCC)

Project Summary
Research in the treatment for diseases of the exocrine pancreas, including chronic pancreatitis (CP),
pancreatogenic diabetes mellitus (DM), and pancreatic ductal adenocarcinoma (PDAC), has been hampered by
disease heterogeneity, the lack of systematically collected clinical outcome measures in longitudinal studies
linked with biospecimens, and slow pace in biomarker and therapeutic development. Given the increasing
incidence and prevalence of CP and its association to PDAC, its complications, high mortality rate, and
associated healthcare cost, the NIH established in 2015 a consortium for the study of Chronic Pancreatitis,
Diabetes and Pancreatic Cancer as multidisciplinary teams to undertake a comprehensive clinical,
epidemiological, and biological characterization of patients with CP (including recurrent acute pancreatitis) to
develop treatments and biomarker tests, and gain insight into the pathophysiology of CP and its sequela: chronic
pain, pancreatic exocrine and endocrine insufficiency, diabetes and pancreatic cancer association.
In the last nine years, the Coordination and Data Management Center (Center) of the Consortium for the Study
of Chronic Pancreatitis, Diabetes and Pancreatic Cancer (Consortium) has provided critical administrative,
regulatory, managerial, logistic, analytic, and financial functions for the consortium, enabling the successful
launch of four multicenter studies (i.e., PROCEED, INSPPIRE 2, NOD, DETECT) that aim to understand the
relationship between CP, DM, and PDAC, and to better define and characterize Type 3c diabetes.
In the next five years, the consortium will be renamed the Chronic Pancreatitis Clinical Research Consortium
(CPCRC), and the Center will be renamed the Data Coordinating Center (DCC) to reflect the revised research
focus on CP, both in children and adults and to pursue and expand the objectives of the former consortium in
these areas. The DCC will further refine, optimize and innovate its time-tested infrastructure, operation
procedures, and organizational structure to provide strong and continued support for the CPCRC’s studies.
Specifically, we aim to (1) provide operation and coordination support; (2) continue the accrual and follow-up for
the two ongoing longitudinal cohort studies, PROCEED and INSPPIRE 2; (3) support the infrastructure for
biomarker development and therapeutic trials, and manage the CPCRC biobank to process, safeguard and
distribute the study biospecimens for the conduct of studies approved by the CPCRC; and (4) design and support
new studies selected by the CPCRC.

Public health relevance
Project Narrative (Relevance to Public Health – 2 or 3 sentences): The proposed study is highly relevant to public health because chronic pancreatitis is associated with a significant disease burden, poor quality of life, and many co-morbidities, including an elevated risk of pancreatic cancer, the fourth largest killer among all cancers despite a relatively low incidence rate. This proposed project generates fundamental knowledge on the natural history of chronic pancreatitis and supports the development of effective interventions, diagnostic biomarkers, and prognostic tools.